Identifying contributors to racial and ethnic disparities in child occupant safety

Project Abstract
The purpose of this K99/R00 Pathway to Independence award is to enable Dr. Sartin to gain the experience and
skills necessary to become an independent investigator focused on identifying, understanding, and eliminating
disparities in transportation and pediatric unintentional injuries. Dr. Sartin’s primary objective is to utilize a
breadth-to-depth approach that integrates knowledge obtained from population- (breadth) and individual-level
(depth) analyses to understand where and why racial and ethnic disparities in child occupant safety arise across
the crash injury continuum. In the K99 phase of this project, Dr. Sartin will complete multiple research and training
activities to develop knowledge and skills in: (1) advanced epidemiologic/statistical and injury methodologies; (2)
management, analysis, and visualization of large databases; (3) advanced R programming; and (4) effective and
ethical approaches to researching health disparities. Specifically, Dr. Sartin will complete structured coursework
and guided independent study, as well as mentored research with her experienced, interdisciplinary team of
mentors and advisors to successfully achieve three aims. In the K99 phase, Dr. Sartin will utilize innovative
methods to: analyze a large, unique source of state-level data to determine population-level frequency of child
restraint system use across racial/ethnic populations (Aim 1a); identify factors that contribute to lower rates of
child restraint system use in minority groups (Aim 1b); and assess how child, driver, and vehicle characteristics
impact racial and ethnic disparities observed in child occupants’ crash injury severity (Aim 2). In the R00 phase,
Dr. Sartin will recruit recently crash-injured children and a caregiver to participate in a mixed-methods, pilot
cohort study—involving surveys, clinical assessments, and semi-structured interviews—to assess short- and
long-term mental and physical health outcomes (Aim 3). Findings of the R00 study will serve as preliminary data
to support Dr. Sartin’s first R01 proposal. In addition to preparing Dr. Sartin for an independent research career,
this work is significant in that it will directly address several critical gaps in child occupant safety. While overall
child occupant fatality rates have decreased since 1975, ~3 children die in crashes each day and ~100k more
are treated each year in emergency departments for injuries. Further, while overall fatalities have declined, racial
and ethnic disparities have widened such that Black children are twice as likely as White children to die in a
crash. The high burden and costs of crashes on children ($530M annually) coupled with clear disparities
underscore the critical need to enhance child occupant safety, in particular among racial and ethnic minorities.
The knowledge gained by this project will ultimately reduce overall rates of pediatric crash injury and death by
bolstering protective efforts for the most vulnerable children. This K99/R00 is directly aligned with the NICHD
2020 Strategic Plan’s emphasis to understand the contribution of social, economic, structural, and regional
factors that contribute to health disparities, and the Pediatric Trauma and Critical Illness Branch’s mission to
prevent, treat, and reduce all forms of traumatic injury across the continuum of care.

Public health relevance
Project Narrative Despite decades of research, advancements in vehicle technology, and various intervention and legislative efforts, stark racial and ethnic disparities in child occupant safety persist. This research will use a breadth-to- depth approach that integrates knowledge obtained from population-level analyses (breadth) and individual-level data collection (depth) to identify why and where racial and ethnic disparities arise in child occupant safety, with a goal of directly informing future interventions and policies. This work is the next critical step to bolster protective efforts for the most vulnerable children, and will ultimately reduce the burden of crashes experienced by children, their families, and society.